Identifying the neural correlates of mental simulation in multi-step planning

PROJECT SUMMARY/ABSTRACT
Planning, the ability to mentally simulate possible futures toward a goal, is essential for
everyday decision-making. Indeed, many psychiatric and neurological disorders are associated
with dysfunctions in planning, including obsessive-compulsive disorder and autism spectrum
disorder. However, the neural mechanisms underlying complex planning remain poorly
understood, partly due to the disconnect between the oversimplified tasks used in most
neuroscience studies and the rich, strategic planning required in real life. This project addresses
this challenge by studying the neural basis of planning in "Four-in-a-Row," a game that captures
the essence of complex planning while being amenable to detailed computational modeling. We
posit that the brain plans by simulating promising sequences of future actions and evaluating
their outcomes using a feature-based heuristic – a process we formalize in a computational
model. To track this process in the brain, we will combine fMRI and MEG neuroimaging
techniques and eye-tracking measurements, leveraging the computational model to guide the
analyses of these data. Aim 1 will employ fMRI to identify brain regions representing the value
of potential moves and the features involved in their evaluation. This spatial mapping will reveal
where value and decision signals are computed in the brain during planning. Aim 2 will leverage
the high temporal resolution of MEG to track the dynamic unfolding of mental simulation,
allowing us to pinpoint when specific value computations and representations of possible future
scenarios occur. Aim 3 expands our investigation by applying deep neural network models to
extensive gameplay data, intending to uncover distinct, individualized planning strategies and
improve our characterization of the neural mechanisms of complex planning. Overall, we will
obtain a unified picture of planning, linking behavior, spatial neural correlates, and the temporal
dynamics of this complex cognitive process. This research will be the first to provide direct
neural evidence of mental simulation during planning, promising fundamental insights into a
core aspect of human cognition. Our interdisciplinary team, with expertise in computational
modeling, neuroimaging, and machine learning, is uniquely equipped to carry out this innovative
research program. Although immediate translational applications are not the focus, our findings
could eventually enhance the behavioral and neural characterization of planning deficits in
various mental health disorders, potentially informing the design of more targeted interventions.

Public health relevance
PROJECT NARRATIVE This project aims to understand the neural mechanisms underlying multi-step planning, a cognitive process disrupted in many neurological and psychiatric disorders. By understanding how the brain simulates future events to make decisions, our work could lead to new strategies for diagnosing and treating planning-related impairments, ultimately improving mental health outcomes and enhancing quality of life.